High Content Imaging System for Microscopy-Based High-Throughput Assays

PROJECT SUMMARY / ABSTRACT
High content microscopy assays allow to simultaneously visualize and quantify many features in complex
biological systems. Over the past years, high content microscopy-based screening has been increasingly
recognized as an integral approach for identifying and characterizing novel therapeutic targets in the
cellular context. The technology has also been widely adopted by pharmaceutical companies and
academic screening cores for probe and drug discovery via phenotypic screening. Here, Yale Center for
Molecular Discovery (YCMD) requests funds to purchase state-of-the-art ImageXpress Micro high
content screening system integrated with a robotic platform to replace an outdated system which
manufacturer discontinued. The requested system would meet the needs of current projects and offer
major additional acquisition and analysis capabilities that are not currently accessible, ultimately
expanding the scope and increasing the throughput of many biomedical research programs.
YCMD (The Center) is a core facility uniquely suited for hosting and maintaining the instrument and for
providing high content screening services. The Center specializes in high-throughput assay development,
provides a diverse collection of small molecules and genetic libraries, and maintains a sophisticated
infrastructure, including cutting-edge instrumentation and analysis databases, to support screening.
Staffed with a highly experienced team and supported by the university, the Center serves a diverse and
broad user base, annually supporting projects from over 40 different laboratories from various
departments across Yale and non-Yale institutions. Notably, the core supports at least ten major high-
throughput microscopy-based projects each year and has a strong track record of successfully executing
image-based projects for translational biomedical programs.
This application is supported by nine faculty members identified as major instrument users, and two minor
users, encompassing seven different Yale departments and an external institution. Their innovative
programs span a wide range of basic, translational, and clinical research areas and address many
therapeutic indications including cancer, heart diseases, developmental and neurological disorders, and
skin diseases. Majority of the users have NIH funding, and their translational research is also supported
by the Department of Defense and private and institutional funds. High content screening system is critical
to support high-throughput research of the users, and ImageXpress Micro system requested in this
application would represent a major opportunity to implement and advance current and future
transformative biomedical programs which have direct implications for human health.

Public health relevance
PROJECT NARRATIVE The microscope requested in this application will help scientists visualize healthy cells and understand how the structure and the function of the cell changes in the disease. It will also allow to efficiently test thousands of candidate drugs, ultimately enabling discovery of new therapeutic approaches and potential treatments for diseases such as cancer, skin disorders, heart disease, developmental and neurological disorders, and blindness.